Chemotherapy induced MASP activation and ovarian cancer metastasis

SUMMARY
Metastasis is the leading cause of high mortality in epithelial ovarian cancer (OC) patients. The most common
and insidious OC subtype, high-grade serous ovarian cancer (HGSOC), is often diagnosed after it has already
metastasized beyond the primary tumor site. Current clinical management for HGSOC is based on cytoreductive
surgery and combination platinum/taxane chemotherapy (CPTX); however, effects are not durable, with as many
as 80% of patients experiencing tumor recurrence and acquired resistance to chemotherapy. OC commonly
metastasizes by shedding of tumor cells from the ovarian or fallopian tube surface epithelium directly into the
peritoneal cavity where the tumor cells disseminate, attach to the mesothelial lining and invade surrounding
organs. Clinically approved chemotherapies are designed to slow or stop tumor growth; however cancer cells
can evolve between chemotherapy cycles, acquiring properties that allow them to survive and successfully
disseminate, developing into life-threatening metastases. Different targeted molecular therapies are being
developed as combination or maintenance therapies for OC that primarily target tumor growth, but have little
effect on metastatic processes. Notably, several lines of compelling evidence point to the ability of clinically
approved chemotherapy that is effective for treating primary tumors to potentiate metastatic dissemination of
cancer cell subpopulations and paradoxically drive metastatic disease. We have discovered that chemotherapy
used in first line treatments inadvertently activates tumor-cell associated membrane-anchored serine proteases,
or MASPs, that promote tumor dissemination and metastasis. Our data emphasize the importance of determining
whether anti-cancer agents aimed at cell division could inadvertently increase ovarian tumor persistence and
tumor recurrence. The goal of this research is to determine specific mechanisms by which antimitotic CPTX
therapy inadvertently stimulates tumor-associated MASP activities that enable establishment of favorable
mesothelial niches and promote metastases so that effective blocking strategies can be developed. The research
plan will use patient-derived primary human ovarian tumor cells, patient ascites, genetically-defined ovarian
tumor cell lines, and preclinical organotypic and immunocompetent mouse models to 1) define CPTX-induced
molecular mechanisms that drive overactivation of MASPs, and 2) systematically define cell-specific
determinants and functional mechanisms of intraperitoneal metastasis caused by CPTX-induced activation of
MASPs. At the completion of this study, we anticipate that we will uncover important chemotherapy-induced
metastatic mechanisms that can be exploited to develop more effective therapeutic strategies to specifically
neutralize chemotherapy-driven pro-metastatic changes.

Public health relevance
Metastatic epithelial ovarian cancer is the leading cause of gynecologic cancer death. Conventional chemotherapy aims to slow or stop tumor growth, however tumor cells can continue to evolve between chemotherapy cycles, acquiring properties that allow them to survive and successfully disseminate, developing into recurring life-threatening metastatic tumors. This project aims to understand how chemotherapy used in first line treatments inadvertently activates tumor enzymes that promote metastasis, with the goal of identifying more effective therapeutic strategies to neutralize chemotherapy-driven metastatic disease and improve patient survival.